Epilepsy Research Training Program

Summary:
We propose to renew our 20-year-old UCI Training Program in Epilepsy Research which supports a total of
four predoctoral and postdoctoral trainees. Epilepsy is the third most common brain disorder, and one that
affects the young preferentially, with a tremendous loss of human potential. Surprisingly, Epilepsy is relatively
understudied guide and develop the next cohorts of diverse, outstanding trainees and provide them with state-
of the art conceptual, technical, quantitative and scientific rigor approaches to the understanding and
underfunded; thus, there is a major unmet need to encourage and train the new generation of the Epilepsy
Investigator Workforce. Our program has strived and succeeded in shepherding a robust and diverse cadre of
pre- and postdoctoral trainees who are now engaging in Epilepsy and Neuroscience Research and Education,
the majority in Academia and Industry. We now propose to of Epilepsy and its co-morbidities, as well as
professional skills for their career development. Our progress to date and the current proposal demonstrate
that we have the experience, environment, resources and passion to accomplish these goals.

Public health relevance
Narrative We propose to renew our 20-year-old UCI Training Program in Epilepsy Research. Epilepsy is the third most common brain disorder, and one that affects the young preferentially, with a tremendous loss of human potential. Surprisingly, Epilepsy is relatively understudied and underfunded; thus, there is a major unmet need to encourage and train the new generation of the Epilepsy Investigator Workforce. Our program has strived and succeeded in preparing a diverse groups of students for their Research Career in Epilepsy and Neuroscience Research. We hope to continue this effort and educate the next generation of diverse, outstanding trainees and provide them with state-of-the-art approaches to the understanding of Epilepsy and its co-morbidities, as well as professional skills for their career development.